Core B-Musculoskeletal Structure and Strength Core

PROJECT SUMMARY (CORE B)
The examination of structure and strength is crucial for studies of musculoskeletal biology and medicine.
The rigorous assessment of these outcomes requires substantial expertise, a battery of specialized
equipment, well-trained users, validated protocols, and regular systems maintenance and calibration. We
will support critical infrastructure, shared facilities, training, full-service data acquisition, and project
consultations for evaluating structure and mechanical behavior of musculoskeletal tissues. We will achieve
these goals through following specific aims: Aim 1 – Maintain protocols, equipment, and enable the
imaging/mechanical testing of musculoskeletal structures and tissues. Standard imaging techniques
include plane radiography, dual-energy X-ray absorptiometry (DeXA), micro-computed tomography
(microCT), and high-resolution X-ray microscopy. Standard mechanical testing techniques include long-
bone bending, vertebrae and intervertebral disc compression, torsion testing for bone/fracture calluses,
fracture toughness in bone, and bone and cartilage microindentation. Investigators have an ongoing need
for musculoskeletal imaging and mechanical testing that can generate quantitative outcomes. By assuring
that the equipment is properly maintained and accessible to users, we can continue to be an effective
resource for the Research Community to generate quality data with broad impact. Aim 2 – Provide
training, engage users, and assist with data compliance to optimize quality, efficiency, and impact.
Present workshops and seminars, and produce training documentation (SOPs and videos) to educate users
and ensure best-practices are followed for rigor and reproducibility. We will consult with investigators prior
to the initiation of studies to promote integrate approaches within Core B and across other Cores. To
support the Research Community with NIH Data Management Compliance, we will assist users in exporting
and curating datasets. Aim 3 – Enhance state-of-the-art infrastructure and drive innovation within the
Research Community. Collaborate with the Research Community to develop and validate new protocols
with the goal of broad adaptation and dissemination. Continue to validate and disseminate new techniques
broadly, such as the osteocyte lacunar network imaging and time-lapse microCT for nondestructive
measurements of bone remodeling. Through regular solicitation of user feedback, we will continue to be
responsive to needs of the Research Community. In summary, Core B will provide critical access and
support to members of our dynamic Research Community to enable cost-effective utilization of methods to
quantify morphology and mechanical properties from diverse musculoskeletal tissues. Through our efforts
we will enhance research productivity and rigor, provide training and access to state-of-the-art and
emerging techniques, and enhance innovation in the Research Community.